Advanced Molecular Probes and Cell Engineering Tools for Accurate Single-Molecule Analysis of Signaling in Individual Cells

PROJECT SUMMARY
Cell signaling is the process by which cells communicate with each other and with their environments and its
regulation is critically important to maintaining homeostasis at the tissue, organ, and organism level. Because
aberrant signal transduction underlies the pathogenesis of most diseases, the study of cell signaling has
become a central part of cell and molecular biology research. However, current methodologies to analyze cell
signaling suffer from multiple technical limitations. For example, signaling pathways are traditionally analyzed
using biochemical methods that average measurements obtained across thousands of cells simultaneously,
providing an impression of the global signaling landscape that ignores underlying cell-to-cell variability, as well
as dynamic localizations and translocations of the molecular mediators. While fluorescence microscopy has
the potential to overcome this limitation by enabling real-time observations of rapid molecular events at sub-
micron resolution, these methods do not provide sufficient sensitivity or signal stability to observe discrete
single-molecule events. Recently, our ability to image cellular processes has been transformed by single-
molecule imaging due to advances in fluorescent quantum dot probes and bioorthogonal labeling chemistries.
Simultaneously, advanced cell engineering tools like CRISPR/Cas9 and micropatterning now allow us to
precisely control cellular genotype and morphology to facilitate imaging of single proteins in a native cellular
context. These technologies have matured individually and we propose that they are now primed to be applied
as a cohesive suite of tools for precise mapping and analysis of cell signaling. As such, the goal of this
proposal is to develop and validate three technologies that in combination will enable intracellular single-
molecule analysis including (1) QD labels for intracellular imaging of molecular processes, (2) native protein
tagging through gene editing for efficient conjugation, and (3) automated image analysis algorithms optimized
to spatially map processes in micropatterned cells across different time scales and registered intracellular
locations. We anticipate that by simultaneously advancing these technologies, we will create a novel platform
to study cell signaling in living cells with single-molecule resolution in real-time. We will accomplish our
objectives through the collaborative work of a multidisciplinary team integrated by Dr. Andrew Smith, who is an
expert in optical probe engineering and imaging, and Dr. Pablo Perez-Pinera, who has extensive expertise in
gene editing and genome engineering. Their laboratories have been working together for years to initiate the
work described in this application. Conceptually, this platform is a revolutionary method to analyze cell
signaling and, therefore, it will not only improve our understanding of essential biological processes, but can
also enable the development of therapeutics that target these pathways with unprecedented precision and
efficacy.

Public health relevance
NARRATIVE Signal transduction mechanisms are conserved across eukaryotic organisms and fundamentally regulate human development, health, and disease. However, the biochemical methods that traditionally have been used to study cell signaling lack sensitivity and fail to provide spatiotemporal resolution, which are critical parameters to understand these processes at a systems level. Here we propose to develop a novel single-molecule imaging technology that will enable analysis of cell signaling with unprecedented precision and resolution and will ultimately transform our understanding of biology, human physiology, and pathology.